Elucidating the molecular mechanisms of metastasis organ tropism

PROJECT SUMMARY
The molecular and cellular biology of metastasis is multifactorial, and this complexity contributes to the
challenge of treating patients with metastatic disease. One of the challenges of metastasis biology is to
determine why certain tumor subtypes have preferential sites of metastasis: e.g. TNBC/Basal-like breast
cancers tend to metastasize to visceral organs, while ER-positive/Luminal breast cancers tend to metastasize
to the bone. In addition, once metastases are established at a distant site, it is critical to understand how these
tumors interact with the local microenvironment and identify the tumor-to-organ crosstalk might be occurring to
sustain tumor growth. This proposal aims to address these questions by utilizing a comprehensive and
carefully curated dataset of paired human primary tumors and metastasis samples, and a similar paired
Genetically Engineered Mouse Mammary tumor models dataset. We seek to identify the molecular
determinants of lung and liver organ-specific metastasis using supervised learning approaches and this
extensive human and in vivo mouse models breast cancer data set. Lastly, using spatial transcriptomics, we
will characterize unique organ microenvironments to identify critical crosstalk that contributes to sustained
tumor growth, thus possibly offering a new means for therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Cancer spreading to other body parts, also known as metastasis, is a complex process, making it difficult to treat. In addition, specific types of breast cancer tend to spread to specific organs, which we call breast tumors with preferred sites of metastasis. Our goal is to uncover the factors governing metastasis going to preferred sites and overall metastasis rates using unique human specimens, mouse models of breast cancer, genomic data, and advanced machine-learning approaches.